Predictive Structure-based Guidelines for Identifying Optimal PEGylation Sites within Proteins

? DESCRIPTION (provided by applicant): Our goal is to develop structure-based tools for identifying optimal PEGylation sites within peptides/proteins and to use these tools to enhance peptide/protein pharmacokinetic properties. Our central hypothesis is that optimal PEGylation sites should be characterized by the ability of the attached PEG to enhance peptide/protein conformational stability. Our rationale for this hypothesis is that unstable, unfolded or misfolded proteins tend to be non-functional and have more pharmacokinetic problems than folded proteins (i.e., are more aggregation-prone, more susceptible to proteolysis, and more readily recognized by antibodies). Therefore increases in protein conformational stability should also enhance protein pharmacokinetic properties However, current PEGylation efforts lack predictive tools for increasing protein stability; instead, a trial-and-error approach prevails, which frequenly results in diminished biological activity relative to the non-PEGylated protein. Using our growing molecular-level understanding of PEG-based protein stabilization, we will develop predictive structure-based tools for generating PEGylated peptides/proteins with enhanced pharmacokinetic properties and undiminished function, thereby accelerating the development of better PEGylated protein drugs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our goal is to develop rational tools for enhancing the stability the properties of peptide/protein drugs by attaching an unnatural polyethylene glycol (PEG) polymer to specific protein side-chains. Our central hypothesis is that optimal attachment sites should be characterized by the ability of the attached PEG to enhance peptide/protein thermal stability. If successful, our efforts will lead to peptides/protein drugs with enhanced pharmacokinetic properties and undiminished function.